Developmental Neuroscience Research Core-Supplement

DESCRIPTION (provided by applicant): The Morehouse School of Medicine (MSM) Developmental Neuroscience Research Program (DNRP) is applying for supplemental support to enhance its core facilities in Administration, Cell and Molecular Biology, Imaging and Microscopy for the purpose of increasing the research capacity and advancing the research programs of its investigators.